Harmonization of Cross-National Studies of Aging to HRS--Renewal

Project Summary The goal of this application is to continue our project that facilitates the research network for “Harmonization of cross-national studies of aging to the Health and Retirement Study.” This network supports the development of new international studies with harmonized HRS around the world data, maintains harmonization and data development among existing comparable HRS studies, and fosters a cross-country research agenda.

Public health relevance
Project Narrative This project will continue to support the development of new international studies with harmonized HRS around the world data. The project will also maintain harmonization and data development among existing comparable HRS studies, and foster a cross-country research agenda. There are a number of aims consistent with that objective. First, we will organize biennial harmonization meetings that will bring together the principal investigators of all HRS-family surveys and relevant content experts in the field. The purpose of these meetings will be to improve harmonization among the existing HRS surveys; to support the development of new HRS-like surveys; and to develop a strategy for further innovations to the HRS family of surveys. Second, we will support small-scale pilots that will bring new innovations in survey contents or methodology into the HRS network of studies. Third, we will organize research conferences to further promote these cross- national studies, inviting not only the study teams but also other researchers outside of the network. Our fourth objective will be to foster the development of the new studies in the HRS network so that they can launch their studies successfully and with good comparability with the existing more mature HRS studies. Finally, we will disseminate (1) the meeting reports, summarizing key discussions at the biennial PI harmonization meetings, (2) the results of small-scale pilots, and (3) the conference proceedings through the RAND public websites and promote their availability through other population-center networks and professional associations